Pilot Projects Program

The primary objective of the Phase III Pilot Project Program of the COCVD is to build upon and expand
momentum by providing short-term funding for meritorious pilot studies that focus on obesity as a risk factor for
human diseases. Working in parallel with identified areas of biomedical research strength at our institution, the
program will emphasize support for pilot projects that examine the relationship between obesity and
cardiovascular diseases, type 2 diabetes, cancer and neurodegenerative diseases. The Program will support
studies for junior/new investigators to study obesity as a risk factor for human diseases, established
investigators who include obesity as a risk factor within their area of disease specialization, and
multidisciplinary teams of investigators for submission of programmatic grant applications. Decisions on
support will follow NIH-format review by members of the COCVD during Phase I and II of the program,
supplemented by members with specific expertise (e.g., cancer). Initial scientific merit reviews will be
submitted to the Internal Scientific Advisory Committee for initial ranking determinations, followed by the
External Advisory Committee for their review and input. Pilot Project grants are designed for 1 year ($50,000)
with a second year contingent upon progress. The successes of the program to date in operation and function
will carry into Phase III of the COCVD.